VetLIRN: Expanding Capability and Capacity at the ADRDL

PROJECT SUMMARY/ABSTRACT
South Dakota State University’s (SDSU) Department of Veterinary and Biomedical
Sciences (VBSD) and Animal Disease Research and Diagnostic Laboratory (ADRDL) is
proposing to upgrade our 2 Illumina MiSeq instruments to Illumina MiSeq i100 (1) and i100
Plus (1) instruments. Illumina has announced the sunsetting of our current platform and in
order to maintain Whole Genome Sequencing (WGS) capability and capacity for the Vet-
LIRN network, we will need to update to new WGS technology. The i100 systems would
also provide advantages in run time, disposable cost, and analyst safety.
Specific aims are to acquire and validate the Illumina MiSeq i100 instrument for use in
bacterial sequencing, principally those samples submitted to our laboratory for Vet-LIRN
AMR WGS studies and investigations into petfood related illnesses.
We also aim to acquire and validate the Illumina MiSeq i100 Plus instrument, which will
allow for early detection of emerging and zoonotic pathogens. The instrument will be
validated, with a focus on Highly Pathogenic Avian Influenza (HPAI) in milk, food, and feed
samples.

Public health relevance
PROJECT NARRATIVE In order to maintain capability and capacity for Whole Genome Sequencing (WGS) at South Dakota State University’s Department of Veterinary and Biomedical Sciences (VBSD), we will upgrade our current WGS systems (which will be discontinued by the manufacturer) to new systems that are faster, more economical and more efficient.